CORE GRANT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The core subproject was established to handle central administrative issues relating to the functioning of the Resource. The Annual Flow Course, conferences, interactions with collaborators, service users, the Advisory Committee, NFCR staff meetings, executive committee meetings, preparation of reports and monitoring the Resource budget are handled by the NFCR Core Grant.